Enamel 11 International Conference

Project Summary/Abstract
The proposed Enamel 11 conference is designed to: 1) critically address significant advances in enamel research
that have taken place since the Enamel 10 meeting in Pittsburgh, PA in 2022; 2) promote the further
understanding of the biological, biochemical and physicochemical mechanisms of enamel formation, its
malformation and destruction in vivo and in vitro; 3) encourage communication and collaboration among
attendees from clinical, basic and translational science disciplines; 4) stimulate new ideas that will serve as the
basis for the development of novel biomimetic and therapeutic approaches for the repair and/or regeneration of
the tissue, as well as strategies for the prevention of enamel decay; and 5) disseminate the presented new
knowledge through publication of a meeting proceedings in a peer-reviewed journal, thus broadening national
and global accessibility of critical findings and discussions at the meeting. Furthermore, we plan to use this
meeting to 6) encourage the involvement of new or early-stage investigators, underrepresented minorities
(URM), women, and persons with disabilities in this field of research by providing financial support through
awards for travel to the meeting and career mentorship opportunities at the meeting.
The planned symposium will emphasize new developments in enamel research in particular around
environmental pathologies, ion transport and novel strategies for enamel repair. Enamel 11 will have a profound
impact on enhancing research activities, promoting international and interdisciplinary collaboration among
scientists, providing networking and training to early-stage investigators leading to improvements in oral health
in line with the basic mission of the NIDCR.

Public health relevance
Project Narrative The goal of this application is to seek funding for travel support to promote the attendance of dental and graduate students as well as post-doctoral fellows from the United States to the upcoming 11th International Symposium on Dental Enamel (Enamel 11) from October 13-17, 2025, near Paris, France. Enamel 11 builds on a successful series of international symposia on tooth enamel that began in London in 1964 with subsequent meetings at 3- to 6-year intervals. The symposia have provided an invaluable platform for data dissemination and the exchange of ideas on a broad range of topics and are possibly the most significant scientific gatherings for researchers across the globe in the field of dental enamel. As such, Enamel Symposia are an ideal venue for scientists new to the field to engage with senior and/or renowned scientists over the period of 5 days in a fairly closed environment of resort-style meeting venue.